Manipulating the matrix to improve arteriovenous fistula patency

The preferred vascular access for hemodialysis uses an arteriovenous fistula (AVF) to increase blood
flow through a vein. Successful adaptation of the venous conduit to the arterial-like fistula environment requires
remodeling of the vein wall without excessive wall thickening, enabling mechanical strength to resist
hemodialysis procedures that puncture the AVF wall with large bore needles 3 times a week. However, the
poor maturation and patency of AVF, especially in women and requiring additional re-do procedures and
surgery, reflects our imperfect understanding of the biology of venous remodeling that leads to successful
venous adaptation to the fistula environment. This knowledge gap creates an unmet need for novel
approaches to enhance venous remodeling and thereby increase successful clinical use of venous conduits.
During the funding period, we used an innovative mouse AVF model to show that TGF-β signaling
regulates venous adaptive remodeling to improve AVF patency; activation of both the smad2/3 (canonical) and
tak1 (noncanonical) pathways regulate venous remodeling; and endothelial cell-targeted TGF-β inhibition
regulates both collagen density and smooth muscle cell proliferation to improve AVF patency. We present
exciting new data that: 1) expression of the matricellular protein tenascin-C (TnC) is greatly increased and
colocalizes with the remodeling venous wall; 2) TnC regulates AVF patency and TGF-β signaling during
venous remodeling; 3) TnC expression is not downregulated in failed AVF; and 4) TnC knockout mice have
altered proportions of immune cells in the AVF wall. In addition, we have developed the mouse model further to
incorporate chronic kidney disease (CKD) via 5/6-nephrectomy and these AVF faithfully recapitulate human
AVF maturation. We hypothesize that modulating tenascin-C activity will alter venous remodeling, thereby
improving AVF maturation and patency. We will use our translationally relevant in vivo model, an innovative
tool using nanoparticles for local drug delivery, innovative methodology to analyze the cell composition within
the AVF wall, as well as advanced next-generation analyses using transcriptomics techniques that are
available at Yale, to test our innovative hypothesis with the following specific aims:
Aim I: Determine sex differences in TnC expression during human AVF remodeling in vivo. Aim II: Determine
whether TnC function mediates venous remodeling in mice with CKD. Aim III: Determine whether regulation of
immune cells is a mechanism of TnC-mediated venous remodeling.
A successful outcome of this investigation will have lasting impact by establishing whether TnC
mediates venous remodeling, and thus whether regulating TnC activity is a valuable strategy for clinical
translation to enhance AVF maturation. We will also determine whether reduced AVF maturation in women is
due to sex differences in TnC function as well as in inflammation and/or immunity. We use an innovative
strategy and novel tools and models to alter venous remodeling and thereby improve AVF maturation.

Public health relevance
A cornerstone of several common therapies for human diseases is the use of a vein as a conduit to increase blood flow such as the arteriovenous fistula, the preferred access for hemodialysis. However, fistulae have extremely high rates of both early and late failure, and these poor clinical results lead to patient suffering and extensive expenditure of precious healthcare dollars and other resources for additional re-do procedures and surgery. The work to be accomplished within this proposal addresses the knowledge gap in the biology of venous remodeling that has created a serious unmet need for novel approaches to enhance venous adaptation to the fistula environment and enable successful long-term use of venous conduits in both women and men.